GD2 CAR-T CELL THERAPY CLINICAL TRIAL SITE ADMINISTRATION AND CELL DISTRIBUTION LOGISTICS

Support to manage cellular product distribution logistics for an autologous CAR T-cell study in pediatric neuroblastoma and osteosarcoma.